ISLET CELL ANTIBODIES AND AUTOIMMUNITY

Establish incidence of islet cell antibodies in patients with diabetes mellitus, thyroid and adrenal disease, Turner's syndrome, and Down's syndrome in their immediate families. Are islet antibodies a marker of prediabetines?